Administrative Core - Telehealth Research and Innovation for Veterans with Cancer (THRIVE)

SUMMARY
We propose a center called Telehealth Research and Innovation for Veterans with Cancer (THRIVE), and we
will use the entire Veterans Health Administration (VA) health care system as our Clinical Practice Network.
The overarching goal of the Administrative Core is to ensure the smooth functioning of each aspect of THRIVE
and the seamless integration of its components.
Specifically, the function of the Administrative Core breaks down into five aims: (1) Project management – The
Administrative Core will provide centralized project management and research assistance for all THRIVE
projects including the Pragmatic Trial, the Research and Methods Core, Pilot Studies and the Clinical Practice
Network. Project management responsibilities will include hiring and management of project staff; project work
plan development and management; monitoring initial and renewal submissions to the IRBs; oversight of the
Data and Safety Monitoring Plan; scheduling and meeting management; and communication across projects
and externally. (2) Scientific planning and integration – The Administrative Core will lead the timing and roll-out
of the Pragmatic Trial and pilot studies, as well as coordination and integration across projects and THRIVE
components. It will also coordinate feedback from the national External Advisory Board and coordinate an
Annual Project Meeting. (3) Fiscal management – THRIVE will take place within a national health system and
will involve several consortium agreements. The Administrative Core will manage all Center budgets and
oversee the Consortium Agreements, as well as monitoring compliance with fiscal regulations. (4) Training –
The Administrative Core will oversee training and mentoring of junior faculty in research on virtual care,
oncology and health equity. (5) Dissemination – In conjunction with the Research and Methods Core, the
Administrative Core will oversee dissemination of Center results and deliverables to both internal and external
stakeholders.